SilverBills: A Financial and Legal Tech Tool for Caregivers

ABSTRACT
Financial and legal management for persons with dementia (PwD) is a crucial responsibility of
caregivers. This responsibility adds to the stress and strain of caregiving. Current technology
tools that help with bill management and budgeting often require a high degree of technical
expertise and provide an insufficient degree of personal support to address the caregivers’
needs. Current approaches to financial management are typically aimed at technologically
savvy millennials rather than caregivers. Additionally, these approaches do not address the
need for safe and accessible storage of legal documents. Thus, the current solutions available
for these tasks are a mismatch for caregivers. We will address the lack of effective financial
management and legal support for caregivers of PwD by building features on our existing
SilverBills (V1) product that simplify financial management, provide a supportive communication
tool and a vault for critical legal documents. Using proprietary technology, SilverBills receives,
scrutinizes, stores, and pays bills on behalf of clients. SilverBills intends to use this NIH grant to
further develop its technology and tailor capabilities to specifically address the needs of
caregivers. The goal of this project is to decrease the stress and strain on caregivers of PwD, by
providing a simple, safe, and effective financial and legal management tool. The objective of the
administrative supplement to our existing Phase II grant (award number 1R44AG074126-01) is
to receive technical and business funding to further minimize risk. The proposal is to use the
additional funding to become SOC 2 (Health Information Trust) compliant. SOC 2 certification
determines that SilverBills has met industry-defined mandates and maintains the highest
standards of cyber risk management and patient data loss prevention. Our central hypothesis is
that SOC 2 certification will enhance our security protection beyond cyberthreats. We aim to
uphold that the SOC 2 certification optimizes our efficiencies and keeps our internal intelligence
protected. As outlined in the parent grant, in collaboration with researchers from the University
of Denver, we will assess caregiver burden and physical, financial, and emotional distress. The
administrative supplement for Technical and Business Assistance will benefit the study as the
participants data and software used will have the highest level of compliance and security.

Public health relevance
PROJECT NARRATIVE Cybersecurity threats increase every day and, accordingly, the cyber-attacks become more sophisticated with time. It is necessary to obtain the highest level of health information compliance. The goal is to use the additional funds to achieve SOC2 Compliance. This, in turn, will continue improve wellbeing for caregivers of persons with dementia through our Financial and Legal management tool. We will use the funds provided to hire New England Safety Partners to assist us in our efforts to gain the SOC2 certificate. Edward Gardner leads New England Safety Partners and will perform the documentation and asset classification for the certification and liaise with all internal external stakeholders.